Trace Elements in Biology and Medicine

PROJECT SUMMARY
The 2024 FASEB Conference on Trace Elements in Biology and Medicine will take place in Melbourne, Florida
from June 12 – 16, 2024. This conference, the 17th iteration of this biennial meeting since 1983, is designed to
bring together a diverse group of researchers to share and discuss the latest findings in trace element research.
Trace elements such as iron, copper, zinc, manganese, and selenium play critical roles in biology, nutrition, and
health as illustrated by the wide range of disorders and diseases associated with imbalances in these essential
micronutrients. A notable strength of this conference series has been its ability to unite basic scientists focused
on the structural and molecular details of trace element homeostasis in diverse model systems with clinical
scientists/physicians studying the direct impact of trace elements on human health, nutrition, and disease, thus
bridging the gap between basic and applied science. By integrating molecular and biomedical research, this
conference has been highly successful in fostering fruitful collaborations across disciplines and in identifying
novel systems and approaches to solve problems related to micronutrients and health. The program will span a
range of scientific interests ranging from cellular and systemic trace element transport and homeostasis, trace
elements and disease, metal signaling, and nutritional aspects of trace elements. The meeting also includes a
careers workshop, a “meet the experts” event, two flash talk sessions, and informal group activities, which
provide opportunities for trainees and early career investigators to gain additional knowledge and cultivate
professional skills. The ultimate goal of this conference series is to provide a forum for education, collaboration,
and inclusiveness in order to foster further scientific advancements in the role of trace elements in biology, health,
and disease.

Public health relevance
PROJECT NARRATIVE The 2024 FASEB Science Research Conference on Trace Elements in Biology and Medicine will bring together researchers performing the latest, cutting-edge research that advances our understanding of the roles of trace elements in biology, nutrition, health, and disease. Trace elements such as iron, zinc, copper, manganese, and selenium are essential for life, and imbalances in their uptake, distribution, storage, or excretion result in a large number of nutritional and metabolic disorders. This conference plays a critical role in bridging basic and applied research in trace elements and in training the next generation of scientists in this exciting and expanding field.